U-RISE at Hampton University

Abstract. There is an urgent need to expand the number of underrepresented minorities in STEM with the goal
of increasing diversity in the field, thereby strengthening the country's capacity for research and innovation and
filling gaps in the workforce. Hampton University is the ideal institution to continue leading this initiative as we
have a long record of accomplishment of producing highly qualified STEM professionals. Historically Black
Colleges and Universities (HBCUs) such as ours have been very successful in fostering Baccalaureate degree
attainment in general, while also fostering the attainment of advanced degrees. The Hampton MARC Program
made impressive strides in achieving its stated goals to prepare Hampton graduates to be leaders in biomedical
research by improving their preparation for PhD programs as well as future research careers. The Program
completed the training of 12 MARC Scholars all of whom graduated within 4 years and entered into doctoral or
PREP programs. Beyond the direct impact on the MARC Scholars, the MARC program has positively affected
more than 400 non-MARC/ non pre-MARC Hampton students who majored or did not major in Biomedical
sciences. Building on the MARC program at Hampton, the proposed U-RISE program will focus its effort of the
following three (3) aims: 1) To increase the number of students from Hampton pursuing and matriculating in PhD
or MD/PhD programs in biomedical sciences; 2) To implement a pre-U-RISE curriculum designed to: a) increase
the number of students interested in research careers; b) improve STEM retention rates; and c) increase the
number of students eligible for U-RISE by improving academic performance and achievement; and 3) To
implement effective mentoring and enhanced opportunities for pre-U-RISE and U-RISE Scholars through formal
mentor training and engagement of U-RISE faculty in program activities. Overall, the proposed curriculum and
activities will continue to enhance students’ skills and prepare U-RISE Scholars, Affiliates, and other highly
motivated Hampton students for entry into top-ranked biomedical PhD or MD/PhD programs. Collectively, the U-
RISE Program activities will enhance competitiveness during graduate studies and continue to increase the
likelihood of Hampton students graduating from prestigious graduate programs, pursuing research careers and
receiving NIH funding. In addition, the proposed program improves mentoring capacity at Hampton.

Public health relevance
Project Narrative. There is an urgent need to expand the number of underrepresented minorities in STEM. Hampton University proposes the implementation of the U-RISE program which endeavors to: 1) increase the number of students interested in research careers; 2) improve STEM retention rates; 3) improve academic performance and achievement in training eligible departments; 4) increase the number of students from Hampton pursuing and matriculating in PhD or MD/PhD programs in biomedical sciences; and 5) implement effective mentoring and enhanced opportunities for pre-U-RISE and U-RISE Scholars through formal mentor training and engagement of U-RISE faculty in program activities. Overall, the proposed curriculum and activities will continue to enhance students’ skills and prepare scholars for entry into top-ranked biomedical PhD or MD/PhD programs. This program will also improve the mentoring capacity of faculty at Hampton University.